Clonable Nanoparticles

Project Summary: Funds are sought to support a summer research experience for an
undergraduate Chemistry major at CSU, Courtney Solomon. These funds will primarily support
salary. A structured research and career plan that includes phage display to isolate
nanoparticle binding peptides, regular mentorship meetings, and participation in NSF-REU
activities occurring in the department is aimed at helping establish a biomedical career for
Courtney.

Public health relevance
Project Narrative: The parent award seeks to develop cloneable contrast agents that will allow ‘seeing the unseeable’ in cells, tissues and organisms when imaged with electron microscopy or x-ray tomography. The supplement will support an undergraduate student who is working to advance these objectives. The public health relevance is both the training of future biomedical researchers and advancement of molecular imaging in biomedical research contexts.